Administration Core

Core A / Administration Description: The administrative component of this Center will have both scientific and organizational responsibilities. The scientific aspects will be carried out primarily by Dr. Breakefield, who will advise investigators on strategic and technical issues, promote collaboration among projects, monitor the functions and effectiveness of core facilities, and assesses the scientific quality and progress of the work. This will require active interactions with all groups. She will visit the participating laboratories and discuss Center-related projects with P.l.'s and laboratory workers about once every other week. Drs. Gusella and Ramesh are in the Simches Building at Mass. General Hospital which is a 15 min shuttle bus ride from Mass. General East where Dr. Breakefield is located;Dr. Kwiatkowski is located at the Harvard Medical School (HMS) Longwood Campus (30 min shuttle), which Dr. Breakefield visits every other week for courses, seminars, conferences and collaborations. Any scientific problems or organizational issues that arise will be discussed by an advisory committee consisting of Drs. Xandra Breakefield, Daniel Haber, Robert Martuza and Pradeep Bhide, which will meet on an ad hoc basis. Decisions as to how to maximize productivity of the Center, including scientific judgment and budgeting adjustments, will be made by Dr. Breakefield after extensive discussion with this advisory committee and key investigators involved in particular decisions.